Peptide Discovery for Chondrogenesis

PROJECT SUMMARY
In treating a patient with a focal cartilage injury, the greatest challenge in preventing the progression to
osteoarthritis is achieving true functional hyaline cartilage. The long-term goal of this R21 project is therefore to
create an off-the-shelf biomaterial that will fill a cartilage injury of any shape, be implanted arthroscopically, and
regenerate hyaline-like cartilage without the need for costly growth factors or exogenous cells. The secret to
success in achieving a chondroinductive biomaterial resides in peptides, which can be reproducibly synthesized
and conjugated to biomaterials to guide the differentiation of endogenous bone marrow-derived mesenchymal
stem cells (BMSCs). There is a lack of rigorous, systematic, and reproducible methods to identify new peptides
for cartilage regeneration. In this void, we introduce a new peptide discovery strategy to regenerative medicine.
Our approach employs peptide microarrays, which are less labor intensive, less costly, and much faster than
traditional methods (e.g., phage display) to quickly iterate vast numbers of peptide sequences.
In our preliminary studies, we examined TGF-β3 with the peptide microarray approach to identify eight unique
new candidate peptides, and we are pleased to report that three of these newly discovered peptides led to
remarkable upregulation of collagen II gene expression in rat BMSCs. We now have the exciting opportunity to
expand this technology to other growth factors. BMP-6 and BMP-7 for example have demonstrated a powerful
and potent amplification of TGF-β-driven chondrogenesis. The objective of this proposal is therefore to evaluate
the chondroinductivity of our recently-identified TGF-β3 peptides alongside promising new peptides identified
from BMP-6 or BMP-7 via the peptide microarray approach, and then to evaluate leading peptides in a 3D
hydrogel for BMSC chondrogenesis. The chief hypothesis is that chondroinductive peptides will outperform TGF-
β3 in chondrogenesis, to be tested by the following specific aims: 1) To discover additional new peptide
sequences from peptide microarrays, 2) To screen peptides based on chondroinductivity with high-throughput
cell spheroids, and 3) To evaluate refined peptides for efficacy in 3D cartilage tissue engineering.
Aim 1 will identify peptides from BMP-6 and BMP-7 to synergize with the aforementioned TGF-β3-inspired
peptides from our preliminary studies. Aim 2 leverages cell spheroids as a high-throughput tool to screen for
chondroinduction and to verify whether peptide mechanisms of action are consistent with their host protein. After
the Aim 2 screening step, Aim 3 will evaluate leading peptide candidates in a 3D hydrogel system with a fast-
crosslinking pentenoate-modified hyaluronic acid (PHA) biomaterial. The intended outcome of this project will be
a PHA hydrogel with a potent combination of conjugated chondroinductive peptides for future exploration in
cartilage defect repair in vivo. Successful completion of this R21 project offers a new tool for peptide discovery
in regenerative medicine that others can easily adapt, changing how investigators in regenerative medicine
worldwide develop their own bioactive materials to guide the body’s own stem cells to regenerate tissues.

Public health relevance
PROJECT NARRATIVE A major problem in the treatment of injured cartilage is that current methods to regenerate cartilage produce an inferior fibrous tissue prone to breaking down, eventually leading to osteoarthritis. This project presents a new screening method to identify and refine new protein fragments of proteins that support stem cell conversion to true cartilage cells. The project will evaluate the efficacy of stem cell conversion to cartilage cells and production of cartilage by placing stem cells and the leading protein fragments in a 3D material.